Dynamic Functional Image-based Deep Learning for Therapy Assessment in Autism

Project Summary
Autism spectrum disorder (ASD) is a developmental disorder characterized by impairment of social interaction
and communication, as well as repetitive behaviors, with severity ranging from mild to signiﬁcantly disabling.
The prevalence in the United States is rising (currently about 1 in 54 children) and the associated costs are
enormous. In our most recent previous efforts on this project, we have advanced methods for the analysis of
functional magnetic resonance imaging (fMRI), using both task-based and resting-state data, for classiﬁcation,
facilitating identiﬁcation of ASD biomarkers, and using these biomarkers for personalized outcome prediction
for Pivotal Response Treatment (PRT), an evidence-based form of behavioral therapy for ASD. We have made
great strides with our most recent work focusing on deep learning techniques for extracting biomarkers and
predicting outcome using novel strategies focusing on temporal characteristics with Long Short Term Memory
(LSTM) networks as well as spatial characteristics using Graph Neural Networks (GNNs). Improved use and
characterization of the dynamic changes in connectivity appear crucial for advancing performance based both on
our work and the literature. Thus, in our proposed work, we intend to develop a richer, integrated model that can
more fully exploit the complete spatiotemporal characteristics of the data and its inherent dynamics. In addition, a
key issue in deep learning strategies is access to large datasets which remains a challenge, especially given that
ASD is a spectrum with a range of characteristics, severity and comorbidities and that fMRI is a powerful tool that
encompasses many task-based and resting state acquisition paradigms. Comorbidities are a particular challenge
and opportunity in that they have the potential to increase our understanding of the heterogeneous manifestations
of ASD. We propose to further develop and expand the power and impact of our methodology by broadening our
subject base to include ASD comorbidities (e.g. anxiety, ADHD, depression) and multiple treatment strategies. We
will advance our technology by creating a more integrated spatiotemporal analysis combining our LSTM and GNN
approaches. We will use domain adaptation methods to properly exploit multiple fMRI paradigms in conjunction
with secure federated learning strategies to facilitate multi-institutional data usage with privacy. These innovative
approaches will allow us to improve the practicability of predicting quantitative treatment outcomes in ASD and
measuring associated neuroimaging biomarkers.

Public health relevance
Project Narrative Autism spectrum disorder (ASD) is a difﬁcult and growing problem. The goal of this project is to develop sensitive and quantitative image analysis methodology for the study of ASD aimed at measuring brain pathology and using it to characterize and predict response to therapy. This work will advance our understanding of this disorder and its treatment and ultimately inform and guide personalized therapies.